Roles of SARM1 NAD hydrolase in metabolic cardiomyopathy

NAD+ depletion is observed in diseases including heart failure and metabolic cardiomyopathy. Maintaining
NAD+ homeostasis by activating NAD+ synthesis pathways has shown great promise to treat diseases. We
here explore that inhibiting NAD+ consumption will prevent NAD+ depletion and ameliorate heart disease. NAD+
hydrolases catalyze NAD+ degradation to form nicotinamide and ADPR. SARM1 is an intracellular NAD+
hydrolase that is known as an executer of axonal degeneration and promotes mitochondrial dysfunction.
Recent studies showed that SARM1 is activated by increased NMN/NAD+ ratio and SARM1 phosphorylation.
However, the role of SARM1 in metabolic cardiomyopathy has never been reported, and how SARM1 is
activated to cause mitochondrial dysfunction is not known. The overall objective of this project is to investigate
how SARM1 promotes NAD+ decline and regulates mitophagy during metabolic cardiomyopathy. Further
understanding of SARM1 in the heart will lead to a new target for therapeutic development of heart disease.
In our pilot data, we showed that SARM1 deficiency in SARM1-KO mice and in newly developed
cardiomyocyte-specific SARM1-KO mice (SARM1-cKO) protected against metabolic stress-induced
cardiomyopathy, providing the first evidence on the role of SARM1 in causing dysfunction of diabetic hearts.
Pilot data further suggested that NAD+ metabolic and JNK1 phosphorylation signaling may activate SARM1,
and SARM1 promotes mitophagy in diabetic hearts. Based on these results, we propose to dissect the
pathogenic mechanisms of SARM1 in metabolic cardiomyopathy with the three aims. Specific Aim 1 will use
SARM1-cKO mice to determine the impact of cardiomyocyte SARM1 deficiency on type 1 diabetes (T1D)-
induced and diet-induced obesity (DIO)-induced cardiomyopathy. Multi-omics analyses targeting known
mechanistic pathways of diabetic hearts will be performed to identify how cardiomyocyte SARM1 deficiency
protects hearts against the two types of metabolic stresses. Specific Aim 2 will understand how metabolic
stress activates SARM1 to cause compartmental NAD+ decline. We will manipulate NAD+ metabolic and JNK1-
SARM1 phosphorylation signaling to establish how the two pathways activate SARM1 to cause NAD+ decline
in mitochondria or cytosol using compartment-specific NAD+ biosensors. Specific Aim 3 will determine how
SARM1 promotes mitophagy in diabetic hearts. Mitophagy flux impacted by metabolic stress and SARM1
deficiency will be measured by mito-Keima mice. How SARM1 promotes mitophagy via traditional PINK1-
Parkin and/or alternative Ulk1-Rab9 pathways will be examined in diabetic hearts. This project will establish
SARM1 as a new target to promote NAD+ decline mitochondrial dysfunction and metabolic cardiomyopathy.
The results from this project will identify new therapeutic targets linked to SARM1-dependent mechanisms.

Public health relevance
PROJECT NARRATIVE Decline in NAD+ levels contributes to the progression of heart failure. SARM1 NAD+ hydrolase is known as an executor of axonal degeneration, but its role in the heart has not been described. This proposal will determine the mechanistic roles of SARM1 activation in NAD+ decline and mitophagy during metabolic cardiomyopathy.